Structure, Function, and Mechanism of Zinc ABC Transporters in Bacteria

ABSTRACT
Our research laboratory focuses on elucidating the structure, function, and mechanism of
bacterial proteins with relevance to human health. We use a wide array of biophysical, structural,
and genetic techniques to accomplish this. The current work is dedicated to investigating bacterial
ATP-binding cassette (ABC) transporters of the essential metal zinc. These are critical for
virulence in many pathogenic bacteria and differ significantly from zinc transporters in mammals,
making them attractive targets for the development of novel antibiotics. Achieving our research
goals for the next five years will make important progress toward understanding how these
systems may be exploited to treat bacterial infections, particularly for those species that have
become resistant to our current arsenal of antibiotics. These goals include determining the first
high-resolution structures of intact zinc ABC transporter systems from two divergent families,
namely ZnuABC and ZrgABCDE. The latter system was only recently discovered, and virtually
nothing is known about how it functions. Both systems are prevalent in human pathogens
including multidrug resistant organisms. We will also initiate a rigorous assessment of the role of
internal dynamics in the interaction between transporter components and subsequent delivery of
zinc using nuclear magnetic resonance (NMR) and fluorescence spectroscopy techniques among
others. These experiments provide important complementary information on protein motions to
the static, high-resolution structural data available from crystal structures and cryo-EM. Finally,
we will confirm the functions of various zinc transporter components in vivo and in vitro by
generating genetic mutations in relevant species and developing zinc transport assays in
proteoliposomes, respectively. Toward the end of the five-year project period, we will have
amassed sufficient structural information to begin the rational development of compounds to
inhibit bacterial zinc transport as novel antibiotics. The overarching goal of our research lab is to
use structural information to provide new weapons in the fight against antibiotic resistant bacteria,
which pose a significant and growing threat.

Public health relevance
PROJECT NARRATIVE Antibiotic resistance in bacteria is a significant and growing concern for human health that requires the development of more effective antibiotics. Transporter proteins are essential to enable pathogenic bacteria to acquire essential metals such as zinc from the human host, making them attractive drug targets. This project aims to provide information on the structure, function, and mechanisms of bacterial zinc transporters that will enable the development of new therapies against antibiotic resistant infections.